RELAXaHEAD: A Behavioral Approach to Remote Migraine Management in Primary Care

PROJECT SUMMARY/ABSTRACT
Migraine affects over 47 million Americans and is the second most disabling condition globally. Healthcare
utilization rates for migraine are high, with over six million ambulatory visits annually in the US. More than half
of these visits occur in primary care settings. One in ten primary care consultations is for headache, and
migraine accounts for at least 75% of these headache visits. Despite evidence that mind-body interventions
(MBIs) are effective for migraine, these treatments are vastly under-utilized due to limited provider availability
as well as patient-reported barriers, such as time and expense. Access to MBIs is quite limited in primary care
settings where most people receive treatment. New scalable, accessible, and evidence-based MBIs are
needed. Our team conducted multiple pilot studies in many settings to evaluate delivery of progressive muscle
relaxation (PMR) for migraine in a patient-centered smartphone application (app) “RELAXaHEAD”. Our
successful recruitment (over 300 patients to migraine RELAXaHEAD pilot studies and over 200 patients to
other migraine mind-body studies), proven track record of conducting mobile health (mHealth) studies (8
publications using RELAXaHEAD), and expertise in headache medicine, MBIs, clinical trial design, and
adherence collectively position us optimally to expand on this work. In response to the NIH prioritization of
research on chronic overlapping pain conditions and the recent call for fully remote MBI studies, we seek to
conduct a fully powered, entirely remote study to assess the efficacy of RELAXaHEAD (RELAX, app with diary
and PMR) compared to monitored usual care (MUC, app with diary) over a 6-week period (based on prior PMR
studies which showed benefit of PMR at 6 weeks). We will compare clinically meaningful patient-reported
outcomes in patients randomized to RELAX vs. MUC. Outcomes include change in migraine-related disability,
migraine-specific quality of life, and headache days. We will assess both the short-term effects (after 6 weeks
of treatment) and the persistence of benefits for up to 26 weeks following enrollment. We will also explore both
potential mediators of treatment effect (improvement in depression, anxiety, sleep) and potential moderators
(age, sex, race, ethnicity, and education level). We will recruit from primary care faculty group practices and
family health centers in a large academic healthcare system to include a very wide range of patients with
migraine, spanning diverse racial backgrounds and ethnicities, and from both urban and suburban
communities. The long-term goal of the research is to create an evidence-based, scalable, and accessible MBI
for migraine with far-reaching impact in a low-cost manner to improve migraine-related disability, improve
quality of life in people with migraine, and reduce headache days.

Public health relevance
PROJECT NARRATIVE Although migraine affects over 47 million Americans, is the second most disabling condition, and accounts for over 3 million primary care visits a year, few people with migraine access evidence-based mind-body interventions (MBIs) due to difficulty finding providers, and the time and expense involved. We plan to build upon our promising pilot data to conduct a full-scale, fully remote trial of progressive muscle relaxation (PMR), an established effective MBI delivered via a smartphone application (app), in patients with migraine in diverse primary care practices. If successful, we will establish app-based PMR as an effective, safe, scalable, accessible MBI to reduce disability and improve the quality of life of people with migraine.